The lipid amidase NAAA as a therapeutic target for Alzheimer's disease

PROJECT SUMMARY
Current therapies do not alter the course of Alzheimer's disease (AD), a devastating neurodegenerative
illness that affects 5.8 million people in the United States and 44 million people worldwide. Thus, an urgent
goal for research is to identify points of control for neurodegeneration, which may be targeted to slow down
AD progression. In this application, we propose to test the hypothesis that the enzyme N-Acylethanolamine
Acid Amidase (NAAA) is one such focal point. NAAA is a lysosomal lipid hydrolase that converts
palmitoylethanolamide (PEA) into palmitate. PEA is an endogenous agonist of the neuroprotective nuclear
receptor PPAR-α, whereas palmitate promotes neurodegeneration by suppressing the transcription co-
activator PGC1α, a key regulator of neuronal energy metabolism and survival. Preliminary experiments have
shown that NAAA transcription is abnormally elevated in persons with sporadic AD and in various animal
models of neurodegeneration, including the 5xfAD model of AD. In the same models, we found that
pharmacological NAAA inhibition and/or genetic NAAA deletion exert marked protective effects. Based on
these results, we hypothesize that dysfunctions in NAAA-regulated lipid signaling may be critically
involved in the pathogenesis of AD. We have three specific aims. Aim 1. Characterize NAAA-regulated
lipid signaling in mouse models of AD. Using 5xfAD and Tau P301S mice, two mouse lines that capture
distinct aspects of AD pathology, we will identify age-dependent, regionally selective changes in NAAA-
regulated lipid signaling, which might precede and/or accompany neurodegenerative alterations and
cognitive impairment. Aim 2. Determine the impact of pharmacological NAAA inhibition in mouse models of
AD. We will assess the impact of chronic administration of the compounds ARN19702 and ARN16186 – two
brain-permeant NAAA inhibitors discovered by our team – on molecular, morphological and behavioral
markers of disease progression in 5xfAD and Tau P301S mice. Aim 3. Determine the impact of genetic
NAAA deletion in mouse models of AD. Using our conditional NAAA-/- mice, we will generate NAAA-
deficient 5xfAD and Tau P301S mice to evaluate the impact of NAAA deletion on disease progression. In
Aims 2 and 3, we will also explore molecular and cellular substrates for the effects of NAAA
inhibition/deletion using single-cell RNA sequencing. The proposed studies will elucidate the functional roles
of NAAA-regulated lipid signaling in the pathogenesis of AD and, if our hypothesis is verified, will validate
NAAA as a novel molecular target for the treatment of this disorder.

Public health relevance
PROJECT NARRATIVE Forty-seven million people suffer from Alzheimer's disease (AD) worldwide, but there is still no adequate treatment for this devastating neurodegenerative illness. Our lab has recently discovered that persons with late-onset AD, the most common form of this disease, express high levels of an enzyme called NAAA, and that inhibiting the activity of this enzyme markedly attenuates neurodegeneration in a mouse model. Here, we propose a series of animal experiments to determine whether NAAA contributes to AD progression, and whether drugs that block NAAA activity might be used to delay this process.